Role of EZH2 as a Driver and Therapeutic Target of Hepatocellular Carcinoma

PROJECT SUMMARY
Hepatocellular carcinoma (HCC) accounts for over 30,000 deaths annually in the United States and current
therapies provide negligible clinical benefit. Factors that epigenetically silence HCC tumor suppressor genes are
expected to promote tumor development and thus may provide novel therapeutic targets. The histone
methyltransferase EZH2 is the catalytic subunit of polycomb repressive complex 2 (PRC2), a master regulator
of epigenetic silencing. EZH2 is mutated or overexpressed in a variety of malignancies and has been shown to
function as an oncogene in some cancers. Efficacious small molecule inhibitors of EZH2 have been developed
and have shown promising results in clinical trials for certain EZH2-driven cancers and recently received FDA
approval for the treatment of epithelioid sarcoma and follicular lymphoma. Based upon analysis of HCC patient
samples, and experiments involving cultured HCC cells and mouse models of HCC, we have found that EZH2
is an HCC oncogene that is an intrinsic driver of tumor development. This intrinsic oncogenic activity of EZH2 is
due, at least in part, to epigenetic silencing of an ERK-specific phosphatase, DUSP6, resulting in activation of a
mitogen-activated protein (MAP) kinase pathway that stimulates cellular proliferation. Furthermore, we have
demonstrated, in two published studies from our group, that EZH2 suppresses the ability of natural killer (NK)
cells to eradicate cultured HCC cells by epigenetically silencing the gene encoding ULBP1, a tumor cell-surface
activating ligand for NK cells, and suppresses NK cell migration to HCC cells by epigenetically silencing the gene
encoding the chemokine CXCL10. Thus, our published and preliminary results suggest that EZH2 drives HCC
tumor development through both a cell intrinsic mechanism (activation of a MAP kinase pathway that stimulates
cellular proliferation) and a cell extrinsic mechanism (inhibition of NK cell-mediated tumor eradication). In this
application our objectives are to establish these two roles of EZH2 in HCC mouse models, determine the
molecular pathways through which EZH2 promotes tumor growth, and evaluate EZH2 as an HCC drug target.
In specific aim 1, we will establish that EZH2 promotes HCC tumor growth by suppressing NK cell-mediated anti-
tumor immunity in humanized mice, and define the roles of CXCL10 and ULBP1 as critical EZH2 targets whose
epigenetic silencing suppresses NK cell-mediated eradication of HCC. In specific aim 2, we will establish DUSP6
as a critical EZH2 target gene whose epigenetic silencing promotes HCC tumor growth through increased
ERK1/2 phosphorylation. In specific aim 3, we will evaluate pharmacological inhibition of EZH2 alone and in
combination with other anti-cancer agents as a potential HCC therapy. Collectively, the results of the experiments
proposed in this application will elucidate the cell intrinsic and cell extrinsic pathways through which EZH2
promotes HCC tumor growth, and evaluate new therapeutic approaches for HCC.

Public health relevance
PROJECT NARRATIVE Over 30,000 Americans die from hepatocellular (liver) carcinoma (HCC) every year and current treatments do not provide long-term benefit, highlighting the urgent need for new and effective therapies. We have discovered that a protein called EZH2 is required for the growth of HCC tumors, and found that inhibiting EZH2 not only blocks HCC tumor growth but also enhances the ability of the immune system to eradicate the tumor. The results of the experiments proposed in this application will establish the mechanism by which EZH2 functions as an HCC oncogene and evaluate EZH2 inhibitors, alone or in combination with other anti-cancer drugs, as novel HCC therapies.